Preserving Erectile Function by Quantifying the Nerve-Sparing step of the Robotic Prostatectomy

ABSTRACT
Variation in performance between surgeons leads to differences in patient outcomes, but
surgeons cannot improve if they are not aware of the technical considerations for a surgical
procedure that will allow them to improve outcomes. As a prime example, robot-assisted
radical prostatectomy (RARP) for prostate cancer can lead to highly variable rates of patient
erectile function (EF) recovery (10-50%). Yet reliable means of objectively assessing surgeon
performance, that strongly associate with patient outcomes, are generally lacking.
In this project, as a test case for quantifying surgeon performance to improve a patient
outcome, we will focus on assessing a surgeon’s nerve-sparing (NS) dissection quality during
RARP through the evaluation of surgical video and patient outcomes. The nuanced NS step is a
good test case because it is the primary determinant of the quantifiable EF outcome, RARP is a
common procedure (~145,000 cases/year), and surgical video is readily available for analysis.
We will accomplish our objective with three independent, yet complementary aims. Aim 1: We
seek to determine through expert consensus the common technical considerations
necessary to optimally perform the NS step for EF recovery. Aim 2: We will develop an
automated performance assessment pipeline through computer vision analysis of surgical
video. Aim 3: We will develop and validate a skills feedback assessment tool for a proof-of-
concept NS-specific VR simulation.
The primary differentiator of the proposed work is we will quantify the most relevant technical
considerations for tissue dissection driving a patient reported outcome. Surgeons
participating in this study will not only provide data through surgical videos of them performing
the NS step, but they will also contribute real patient EF outcome data from the RARP to
establish the relationship between surgeon skill, patient factors, and EF outcome.
Statistical modeling will delineate the differential impact of surgeon skill and patient factors to EF
outcome. Further, we will harness deep learning-based computer vision to holistically capture all
the numerous facets of NS technique and skill to help determine how they contribute to the
ultimate EF outcome.
The proposed work will enable scalable and actionable feedback, empowering surgeons with
valuable knowledge to maximize surgical outcome. The NS step and EF recovery after RARP
will serve as our test case for future automated assessments to improve outcomes in any
surgical procedure.

Public health relevance
NARRATIVE The proposed work seeks to quantify surgeon performance and build automated assessments grounded in patient-centered outcomes to inform training surgeon on how they can improve. The nerve-sparing (NS) step during robot-assisted radical prostatectomy (RARP) is an ideal test case as it is a commonly performed procedure with significant surgeon technical variation and differences in erectile function outcomes. The knowledge gained from this research will advance other surgeries by improving the methodology of assessing surgical skill in general, objectively evaluating surgeon performance through machine learning, and developing targeted training to improve specific post-surgical outcomes.